Feasibility and acceptability of a peer-led strategy to improve community tuberculosis case finding among non-household contacts in Zambia

PROJECT SUMMARY/ABSTRACT
Three million global tuberculosis (TB) cases remain undiagnosed each year, which is a key factor underpinning
why TB is the leading cause of death among people living with HIV (PWH) and the leading infectious cause of
death worldwide. While community-wide screening for TB in high-burden settings is recommended by WHO and
may reduce community prevalence, it is unlikely to be a scalable TB control strategy. Leveraging trained peers
(recent TB patients) to undertake community-based, systematic TB screening among non-household contacts
of newly diagnosed TB patients, including casual contacts at community venues, may be an efficient and
sustainable strategy to facilitate early TB diagnosis and linkage to care; however, little is known about whether
such a strategy is feasible and acceptable to undertake in low-resource, high TB burden settings.
Through targeted training and strong mentorship in implementation science methods, I will develop and evaluate
a theory-informed, multicomponent, peer-led strategy to undertake community-based, systematic TB screening
among non-household contacts of newly diagnosed TB patients attending two public health facilities in Lusaka,
Zambia. This proposal builds upon the research collaboration I began developing during my infectious disease
fellowship and leverages the robust experience and infrastructure of the Centre for Infectious Diseases Research
in Zambia (CIDRZ). In Aim 1, I will undertake mixed-methods research among key stakeholders to identify
barriers to undertaking TB screening among non-household contacts using peers. In Aim 2, I will use a discrete
choice experiment among TB patients, at-risk community members, and community venue owners, to determine
their preferences for the mode of delivery for the implementation strategy components. Findings from Aims 1
and 2 will inform the design of a multicomponent, peer-led TB contact tracing strategy among non-household
contacts that will be evaluated in Aim 3, during a 6-month pilot to assess its feasibility, acceptability and reach.
My overall training objective is to develop implementation science expertise; I will accomplish this by undertaking
carefully selected coursework, workshops, and seminars, and through the guidance of highly accomplished
mentors who are experts in international Implementation science research, mixed-methods research and
multicomponent TB/HIV implementation strategies. My training objectives sequentially map onto my research
aims and are to: (1) gain experience in the application of mixed-methods for implementation science research;
(2) develop expertise in using implementation science methods to develop multicomponent implementation
strategies; (3) develop a strong foundation in study designs and analysis approaches for interventional
implementation research. My career goal is to be an independent physician-scientist who applies implementation
science methods to improve TB and HIV outcomes in low-resource settings. The findings generated from this
K23 award will inform an R01 proposal to undertake an adaptive, cluster randomized trial evaluating a peer-led,
multicomponent TB case finding strategy in Zambia.

Public health relevance
PROJECT NARRATIVE Systematic screening for tuberculosis (TB) in high-risk populations, including people living with HIV and all persons living in high TB prevalence settings is recommended by the World Health Organization as an important strategy to improve TB control. While community-wide TB screening in high burden settings is unlikely to be sustainable, community-based systematic TB screening among non-household contacts of newly diagnosed TB patients (contact tracing) using trained peers (recent TB patients) may represent an efficient and effective implementation strategy that compliments existing strategies and is sustainable. The proposed research will develop and pilot a theory-informed, peer-led, multicomponent implementation strategy to improve TB contact tracing among non-household contacts of HIV-positive and HIV-negative adults in Lusaka, Zambia.